Inducing transcriptional reprogramming of leukemic B-cells by facilitating transcription factors binding to nascent decondensed chromatin

Project Summary/Abstract
B cell acute lymphoblastic leukemia (B-ALL) consist of Leukemic Blast Cells (LBCs) that become arrested at
distinct stages of B cell development because of underlying alterations in transcriptional and epigenetic
programming. The inability to differentiate confers a capacity for unlimited self-renewal and increased
proliferative capability. Based on the successes in the treatment of the APL leukemia with ATRA and arsenic,
leading to cell maturation and senescence, the differentiation-based therapies became a popular, but rarely
successful, therapeutic strategy. We propose that this strategy has been unsuccessful due to a gap in the
knowledge of the underlying mechanism through which transcriptional reprogramming occurs. My new strategy
is based on our group’s recent observations that differentiation of normal hematopoietic progenitor cells (HPCs)
is dependent on their ability to transiently decondense their post-replicative chromatin upon induction with
lineage specifying cytokines. At the early stages of DNA replication, this decondensed state of nascent chromatin
offers a window of opportunity for lineage-specific transcription factors (TFs) to overcome the barrier of the
condensed structure of nucleosomes at repressed genes and to bind and activate their target sites. Preliminary
results indicate that B-ALL LBCs have lost the inherent ability to open nascent chromatin, thus creating a barrier
in their transcriptional reprogramming that differentiation-based therapies cannot overcome. In this proposal, to
overcome this barrier of condensed nascent chromatin and to reprogram LBCs, I will utilize the following
approach. First, I will pharmacologically ablate H3K27me3 to decondense nascent chromatin by inhibiting
H3K27me3 histone methyltransferases EZH1/2. Second, I will use small molecules to activate inducible
transcription factors, which can then readily bind to their target genes due to the decondensed structure of
nascent chromatin. Cancers are commonly known to accumulate mutations in inducible TFs and receptors; thus,
screens of small molecule inducers for a variety of TFs/receptors will be performed to determine the best possible
inducer for distinct subtypes of B-ALL. Preliminary results provide strong indications that induction by novel small
molecule ligands/inducers may lead to transcriptional reprogramming in B-ALL LBCs, which results in an almost
complete loss of viability of these cells. This strategy has also shown significant promise in increasing the efficacy
of and in decreasing the effective dosages of clinical standard of care drugs, such as steroid hormones.
Furthermore, my results indicate that synchronization of B-ALL cells into the entry of the S-phase greatly increase
the efficiency of our reprogramming strategy. Overall, our conceptual advance is in that we are not attempting to
induce hematopoietic differentiation of LBCs, but rather through decondensing nascent chromatin induce
transcriptional reprogramming to aberrant lineages, which may lead to terminal maturation, and thus to
senescence, reduced proliferation, and cell death.

Public health relevance
Project Narrative This project builds on previous work in which our group observed normal hematopoietic progenitor cells require decondensed nascent chromatin for lineage-specific transcription factors to bind to gene targets for differentiation to occur. B cell acute lymphoblastic leukemia blast cells (LBCs) have lost this natural ability to open nascent chromatin leading to these undifferentiated cells having an unlimited capacity for self-renewal and increased proliferative capability. I propose to overcome the barriers of reprogramming based therapies by pharmacologically decondense nascent chromatin followed inducing transcription factors to transcriptionally reprogram LBCs to non-specific lineages, that may lead to senescence, reduced proliferation, and cell death.